Curation of genetic defects causing combined immunodeficiency and infections in children

ABSTRACT
Defects in over 400 genes have now been linked to the development of primary immunodeficiency disorders
(PIDD). The most severe disorders are known as Combined or Severe Combined Immune Deficiencies (CID or
SCID) because they cause a combination of defects in both cellular (T-cell) and humoral (B-cell) compartments
of the immune system. As a result, they lead to profound susceptibility to infections early in life and premature
death if not treated aggressively with antimicrobials, hematopoietic cell transplant (HCT), gene therapy (GT), or
enzyme replacement therapy (ERT). In the U.S., most patients with SCID are now identified by newborn
screening (NBS) performed on dried blood spots obtained at birth. Since the specific gene defect present in a
patient with SCID has actionable consequences (i.e., dictates the type of aggressive therapy that may be
recommended), patients identified by NBS typically undergo early genetic testing using gene panels or exome
sequencing. Frequently, genetic testing returns a result of one or more “Variants of Uncertain Significance” or
variant(s) in a gene not previously associated with a SCID or CID phenotype. Providers and families are
therefore left to try and gather evidence to determine pathogenicity of a particular gene or variant. This effort
may delay care or lead to a less-than-optimal choice of therapy. A critical need therefore exists for expert
curation of the genetic defects that result in SCID and CID. The objective of this application is to curate the
evidence linking specific genes to a SCID or CID phenotype and the evidence for pathogenicity of all variants
in the 8 most prevalent genes associated with SCID in infants identified by NBS. This goal will be
accomplished with 2 specific aims: 1) Establishment of a Gene Curation Expert Panel (GCEP) to curate
evidence linking genes reported to cause SCID or CID to the development of clinical disease according to
ClinGen criteria, and 2) Establishment of a Variant Curation Expert Panel (VCEP) to curate evidence for
pathogenicity of all variants reported in the 8 most common SCID-associated genes based upon prevalence
among infants identified by NBS. Since immune cells can be readily removed from the body for functional
testing, a wealth of published data exists from basic immunology studies that may inform this work. This
proposal is therefore innovative because it will provide resources to allow GCEP and VCEP panels to link this
wealth of published molecular and functional immunology data with clinical and genetic data from published
cases and public databases. The work is significant and will have an immediate positive impact because
curating evidence about the pathogenicity of genes and gene variants and making it publicly available has
immediate actionable consequences that affect timely choice of therapy as described above. The proposed
research therefore addresses the mission of the NIH and this RFA by focusing on the establishment of Expert
Panels to analyze relevant genetic and functional data with high impact on clinical practice to reduce the
burden of illness and disability and improve the lives of children with genetic susceptibility to infection.

Public health relevance
PROJECT NARRATIVE Patients with the most severe forms of immune deficiency including Severe Combined Immune Deficiency (SCID) and Combined Immune Deficiency (CID) are now being detected at birth by newborn screening performed on dried blood spots obtained at birth, and survival of these patients is typically dependent on the use of aggressive treatments, including bone marrow transplant, gene therapy, or enzyme replacement therapy. This choice can be made most effectively only when a specific disease-causing gene mutation is identified, but unfortunately genetic changes identified in these patients are often difficult to interpret because the evidence proving that a particular gene change causes SCID or CID has not been collected, reviewed and made readily available to providers and families. This project seeks to collect and curate this evidence, making it widely available in publicly available databases.